Nevada Food Safety Task Force Conference

Abstract The Nevada Division of Public and Behavioral Health is requesting funding from the Food and Drug Administration's (FDA) Food Protection Task Force Conference Grant (R13) to enable the Nevada Food Safety Task Force to host their annual conference. The purpose of this conference is so individuals that are concerned about food safety can share recent experiences, current projects, and discuss mutual problems and emerging issues. The attendees are made up of public health professionals, academia, grocers, resort properties, regulatory authorities, food and equipment vendors, consumer groups and the community that are on the front lines of food protection. The Nevada Food Safety Task Force has been hosting this conference since 2002 and has been funded by the FDA since that time. It is important that Nevada continue to hold this very important conference that allows all food related professionals to meet and network which builds stronger relationships and alliances. Conference objectives: 1. Develop an agenda that includes a wide scope of content related to foodborne illness, food safety, bioterrorism, and best practices for foodborne illness investigations. Methods: Invite public health representatives from Nevada's 5 main public health jurisdictions, local and state food vendors, Food establishments, regulatory agencies, and federal partners to include representation from the Food and Drug Administration (FDA), United States Department of Agriculture (USDA), Homeland Security (DHS) and the Federal Bureau of Investigation (FBI) to present on foodborne illness topics. 2. Create collaboration among agencies to provide solutions to common foodborne illness issues. Methods: Encourage agencies to share success stories involving enforcement and use of federal food safety regulations and recommendations. 3. Discuss scientific/technological advances related to foodborne illness. Methods: Invite agencies to present on and discuss new methods and techniques used in promoting food safety and foodborne illness investigations.

Public health relevance
Narrative The Nevada Food Safety Task Force's annual conference improves food protection and awareness in Nevada by bringing together experts who exchange ideas and best practices. By addressing food safety issues that affect the citizens and tourists of Nevada, food protection professionals are able to bring new knowledge back to their respective agencies to implement improved processes. By holding the Nevada Food Safety Task Force's conference annually, we are able to explore relevant events and experiences that affect the health of Nevadan's and Tourists and ensure a safe food supply.